Delaware INBRE CSR Core

Project summary – Centralized Shared Resources Core
In the past, DE-INBRE developed and sustained core facilities housing the advanced instrumentation and
expertise in experimental design/analysis needed to both answer important biomedical research questions and
train Delaware’s biomedical workforce. These efforts, in collaboration with Delaware-based COBRE and CTR
awards, NIH- and NSF-funded equipment grants, and institutional resources from the DE-INBRE network
partner institutions (NPIs), The University of Delaware (UD), Delaware State University (DSU), Nemours
Children’s Health (NCH) and the Christiana Care Hospital System (CCHS), created a rich ecosystem of
research cores across Delaware. However, these efforts highlighted the reality that research core creation was
not enough, and it was also critical for these core facilities to be easily accessible to all of Delaware’s
researchers regardless of home institution. In response, DE-INBRE founded its Centralized Shared Resources
Core (CSR) whose mission is to ensure equitable access to Delaware’s research infrastructure by serving as a
backbone that supports cross core facility and cross institutional communication and collaboration between its
twenty-member core facility network located at four of DE-INBRE’s five NPIs to overcome institutional walls
and other barriers to core facility access. CSR also supports core staff training, targeted investments
supporting instrument acquisition/maintenance, and a core facility access voucher program that allows
investigators to generate key preliminary data using new technologies while training early career scientists,
including DE-INBRE Student Research Program (SRP) funded students, in the use of state-of-the-art research
instrumentation.